Cell plasticity in the origin of gastric carcinogenesis

ABSTRACT
Gastric cancer is the 4th leading cause of cancer-related death worldwide and it most commonly develops
within a carcinogenic cascade from pre-cancerous metaplasia to dysplasia and adenocarcinoma. Metaplasias
first arise as a response to injury through the chief cell transdifferentiation into spasmolytic polypeptide-
expressing metaplasia (SPEM) cells. While this initial process is possibly reversible, oncogenic gene
activation or chronic inflammation can activate SPEM cell plasticity, which promotes SPEM cell progression to
intestinal metaplasia (IM) and dysplasia. This neoplastic process may also lead to transcriptional and
epigenetic changes, and incite cell lineage conversion, where multiple intermediate cell types are produced
that can evolve into cancerous cells, including dysplastic stem cells which may arise during the neoplastic
transition. Furthermore, the oncogenic gene mutation burden may be associated with the cell lineage
conversion and diversification of the dysplastic stem cells to cancerous cells. However, it is not clear whether
the SPEM cell plasticity is responsible for the cell heterogeneity and evolution of pre-cancerous metaplasia to
incomplete IM, which carries a higher risk of patient progression to dysplasia and what mechanisms are
involved in the carcinogenic process. We therefore hypothesize that SPEM cells are key gastric cancer
precursor cells, which display functional properties and cell lineage conversion capacity to drive metaplasia
progression to dysplasia. Our overarching goal is to define mechanisms that control the cell lineage
conversion of reparative SPEM cells towards incomplete IM and more cancerous cell lineages, which display a
higher mutational burden. To address these questions directly, we have established novel in vivo transgenic
mouse models and in vitro metaplastic or dysplastic organoid models derived from transgenic mouse stomachs
following induction of active Kras or from human patient samples with metaplasia or dysplasia. Using these
novel models, we will assess critical SPEM cell lineage derivation and define cell populations that account for
the key transcriptional and epigenetic changes arising during metaplasia progression. We will pursue three
specific aims: First we will assess functional properties of SPEM cells during mucosal recovery or neoplastic
progression following mucosal injury. Second, we will examine regulatory mechanisms of cell lineage
diversification and conversion during metaplasia progression. Third, we will investigate molecular mechanisms
driving cell linage diversification and clonal evolution of dysplastic stem cells to adenocarcinoma. Our studies
will define critical transition points which lead to neoplastic transitions for SPEM cells as the origin of gastric
carcinogenesis. An understanding of regulatory mechanisms in cell plasticity and the ability to reverse such
transitions could lead to therapeutic interventions to prevent gastric cancer.

Public health relevance
NARRATIVE Gastric cancer develops within a carcinogenic cascade from pre-cancerous metaplasia to dysplasia and adenocarcinoma. While the pre-cancerous metaplasia is possibly reversible, a key cell population which is responsible for mucosal recovery or neoplastic progression is to be defined. In this study, we will define mechanisms that control the cell lineage conversion of reparative SPEM cells, which are a major cell component of dysplasia, towards incomplete IM and more cancerous cell lineages.